Translational assessment of brain bioenergetic function in schizophrenia

Project Summary
Schizophrenia is a devastating illness with no cure, affecting about 1% of the population worldwide, costing
billions of dollars annually. The scientific premise for this proposal is based on accumulating imaging,
postmortem, animal model, genetic, and bioinformatics data converging on alterations in the production of
bioenergetic molecules in myriad brain regions in this illness. We previously reported abnormally high levels of
lactate in living patients with schizophrenia that were strongly associated with poor cognitive function. This
finding complements our induced pluripotent stem cell (iPSC) and postmortem work showing higher lactate
levels in schizophrenia in iPSC-derived cortical neurons and postmortem anterior cingulate cortex in subjects
with schizophrenia. Based on this evidence, we hypothesize that diminished cognitive functioning in
schizophrenia is due to impaired bioenergetic metabolism in limbic circuits with increased pathological
generation or utilization of lactate in schizophrenia. Specifically, we posit that there is increased production
and release of lactate from astrocytes, coupled with increased uptake and utilization of lactate, in lieu of
glucose uptake and oxidative phosphorylation, to produce ATP in support of neuronal plasticity in limbic
circuits. This new R01 project uses complementary, but distinct approaches, to examine abnormalities of
bioenergetic function in schizophrenia. For SA1, we will use magnetic resonance spectroscopy (MRS) to
quantify lactate levels and comprehensively characterize patients using neuroimaging, clinical, cognitive,
functioning, and metabolic assessments. For Aim 2, cultured human neurons/astrocytes derived from iPSCs
obtained in SA1 to assess lactate production and utilization challenges. We will further delineate the functional
consequences of lactate production on cellular energy metabolism and neuronal development/function at
molecular and cellular levels in cultured human iPSC-derived neurons/astrocytes. In Aim 3, we will use a
bioinformatics approach to identify lactate-associated targets for cell-subtype specific studies of
biochemical/lactate changes in postmortem brain. Taken together, our aims will comprehensively assess
perturbations of lactate and lactate associated pathways across clinical, tissue culture, and postmortem
substrates in schizophrenia. By developing a more sophisticated understanding of the pathophysiology of
schizophrenia, this project will help identify targets in bioenergetic pathways for development of treatment
interventions for this debilitating illness.

Public health relevance
Project Narrative This project will investigate brain bioenergetic alterations in schizophrenia using a translational approach that includes brain imaging, cognition, functioning, and clinical assessments in living patients, bioenergetics studies in cultured human iPSC-derived neurons/astrocytes, and biochemical confirmation studies in postmortem brain accompanied with bioinformatics. This project will help identify treatment targets in bioenergetic pathways that may improve cognition and quality of life in those with this devastating illness.